Multi-cancer early detection using cell-free DNA methylome analysis

PROJECT SUMMARY
Detecting cancer early is the best way to fight against cancer. The development of the Multi-Cancer Early
Detection (MCED) liquid biopsy tests holds great promise for integrating early cancer detection into routine
clinical care. However, the current MCED tests have unsatisfactory performance for early-stage cancers.
Recently, we have developed a sensitive and cost-effective technology, named cell-free DNA Methylome
Sequencing (cfMethyl-Seq), which uses the cell-free DNA methylome for early cancer detection. cfMethyl-Seq
provides >12-fold enrichment over whole genome bisulfite sequencing in CpG islands. We performed the proof-
of-principle study by applying cfMethyl-seq to a cohort of colon, liver, lung, and stomach cancer patients and
controls, and obtained promising results in detecting and locating these cancer types. Here, we will further
improve the cfMethyl-seq technology and apply it to detect and locate colon, gastric, liver, and lung cancer. We
will validate this MCED test in multiple clinical cohorts. Our multidisciplinary team proposes the following aims:
(1) Continued improvement of the cfMethyl-seq assay for early cancer detection. (2) Continued improvement of
our computational method to analyze the cfDNA methylome assay data. (3) Clinically validate the cfDNA
Methylome assay as an MCED assay with colon/gastric/liver/lung cancers as the first indications. (4) Contribute
to Collaborative Trans-consortium Activities. We have a long-standing collaboration with the industry partner,
EarlyDiagnostics, which will optimize the cfMethyl-seq assay to facilitate its clinical adoption and implement the
computational algorithm in a secure cloud computing platform to facilitate data sharing and decentralized testing.

Public health relevance
PROJECT NARRATIVE This project will develop and validate an MCED test for the early detection and localization of colon/gastric/liver/lung cancers. If successful, it will be transformative in fighting against these types of cancer, and benefit human kind. 1